Variations in long-term fine particulate matter air pollution associations with mortality by particle size, source, and composition - Diversity Supplement

Project Summary Abstract
This diversity supplement will provide Ms. Jania Zenon with invaluable mentorship,
training, and advanced research experience via the recently funded recently awarded NIH
grant entitled "Variations in long-term fine particulate matter (PM2.5) air pollution associations
with mortality by particle size, source, and composition" (R01ES035468). The research portion
of this supplement aims to expand this research to investigate mortality impacts of PM2.5 air
pollution exposures on mortality from Alzheimer’s disease. PM2.5 has been found to be
associated with serious adverse health implications, including increased risk of mortality.
However, there is a limited understanding with respect to effects on neurodegenerative
disorders. Specifically, while there is evidence of an association between PM2.5 and
Alzheimer’s disease, there is a lack of rigorous research on PM2.5 and Alzheimer’s disease
mortality; and there is even more limited research on the impacts of PM2.5 particle source, size
distribution or composition-specific variations in the PM2.5 mass- Alzheimer’s association. The
parent grant focuses on the linkage between variation in PM2.5 size, composition, source and
cardiovascular disease (CVD) mortality in the NIH-AARP Diet and Health Cohort. Ms. Zenon
aims to assess these associations with respect to Alzheimer’s disease mortality in this well-
characterized cohort of over 500,000 older aged participants throughout the United States,
who have been followed since 1995-1996 for mortality and cause of death, individual
characteristics of the participants, and census tract ecologic covariates. She will also assess
the potentially effect modifying of an antioxidant rich diet and residence health opportunity
disparities on these associations. This will enable an assessment of the various potential
particulate matter air pollution exposure associations with Alzheimer’s disease mortality, as
well as investigations into potentially modifiable PM2.5 effect varying factors.

Public health relevance
PROJECT NARRATIVE Long-term exposure to fine particulate matter (PM2.5) air pollution has been indicated in prior studies to be associated with Alzheimer’s disease onset and progression, but there are few studies that have assessed the association between PM2.5 exposure and Alzheimer’s disease mortality, and even fewer on variations in particle origin or characteristics’ effects on PM2.5 exposure associations with Alzheimer’s disease. Utilizing a robust study design with a well characterized human cohort of over 500,000 participants, this Workplace Diversity Supplement research will evaluate this PM2.5-Alzheimer’s disease associations with a focus on particle size, source, and composition exposure variations, and will also evaluate the potentially modifying effects of diet and health opportunity disparity. The information gained from this study will help direct environmentally focused policies, potentially leading to mitigative approaches for such neurodegenerative disorders.